Astrocytic Heparan Sulfate 6-O-Sulfation in Brain Function

ABSTRACT
Heparan sulfate (HS) 6-O-sulfation and mutations in the HS 6-O-sulfotransferases (HS6STs) are linked to
multiple human brain disorders. However, the mechanisms of HS 6-O-sulfation in these brain disorders remain
poorly understood, and current therapies are limited. The long-term goal is to use mouse models to reveal how
disruptions of HS 6-O-sulfation affect brain functions and contribute to brain disorders, with a hope to
eventually develop a cure. The overall objective of this application is to reveal the role and mechanisms of
astrocytic HS 6-O-sulfation in the adult mouse brain. The central hypothesis is that astrocytic HS 6-O-sulfation
regulates behavior and transcriptome in adult mice, and that astrocytic HS 6-O-sulfation regulates astrocyte
transcriptome via the HS/Gpc/Fgfr/Stat pathway. The rationale for this project is that a determination of the in
vivo functions and the associated mechanisms of HS 6-O-sulfation in the brain will offer a strong scientific
basis to develop new therapies for patients with these brain disorders. The central hypothesis will be tested by
pursuing two specific aims: 1) Determine the role of astrocytic HS 6-O-sulfation in adult mouse brain; and 2)
Identify the molecular mechanisms of HS 6-O-sulfation in adult astrocytes. This proposal is innovative because
it uses novel mutant mouse lines and multidisciplinary approaches to reveal a heretofore-unexamined process,
the role and mechanisms of HS 6-O-sulfation in the adult mammalian brain. The expected outcomes are 1) to
provide the first in vivo data to determine the role and mechanisms of astrocytic HS 6-O-sulfation in the adult
brain and 2) to reveal the detailed mechanisms of the HS/Gpc/Fgfr/Stat signaling pathway in adult astrocytes.
The proposed research is significant because it will fundamentally advance our mechanistic understanding of
HS 6-O-sulfation and its signaling pathways in the brain, which will help us to understand HS 6-O-sulfation
associated brain disorders and to develop novel therapies. This project will also provide excellent research
opportunities for the underrepresented minority and female students at the New York Institute of Technology
(NYIT) and will significantly enhance the research environment at NYIT.

Public health relevance
PROJECT NARRATIVE Heparan sulfate and its 6-O-sulfation are linked to human brain disorders such as Alzheimer’s disease, intellectual disability, and autism. The proposed studies aim at revealing how heparan sulfate in an important cell type in the brain regulates brain functions. Results from this work will enhance our understanding of the heparan sulfate signaling in the brain, which will provide scientific foundations to develop a cure for heparan sulfate-associated brain disorders.